Clinical Reporting and Research Informatics Support Services

To provide incremental funding to the base period for Contract: Clinical Reporting and Research Informatics (CRRI)- 47QTCA20D003A- 14D042F0483- Essex Management LLC